CD74 and Wound Healing

Project Summary
The mucosal epithelial barrier becomes disrupted in many conditions such as surgical procedures, trauma,
inflammatory bowel diseases, ischemia, and infections. Epithelial cell regeneration is essential for mucosal
wound closure and healing. Our overall goal is to understand the mechanisms that lead to effective mucosal
wound closure.
This proposal builds on our recent discovery of a novel intestinal mucosal wound repair mechanism involving
CD74 signaling. CD74 is the receptor for the MIF cytokine. Our research is motivated by three important and
innovative questions: What is the mechanism that drives epithelial CD74 receptor expression (Aim 1)? Can we
safely and effectively stimulate CD74 (Aim 2)? What are the functional consequences of genetic variation on
CD74 activity (Aim 3)?
Knowledge gained from these studies will advance our mechanistic understanding of CD74 biology and
mucosal wound repair, and may lead to new therapeutic strategies for promoting mucosal wound healing.

Public health relevance
Narrative There is an urgent public health need to improve our understanding of the mechanisms that lead to effective mucosal wound closure and develop new therapeutic strategies for mucosal wound healing.